Selection of B cell repertoire in senescence

DESCRIPTION (provided by applicant): B lymphopoiesis is severely compromised in murine senescence. While there are defects at several distinct stages in the B lymphopoietic pathway in old age, down-regulation at the pro-B to pre-B cell transition likely has a major role in altering the composition of the B cell antibody repertoire. This transition is particularly dependent upon expression of and signaling by the pre-B cell receptor (preBCR), a complex of immunoglobulin 5 heavy chain associated with the surrogate light chains l5 and VpreB. Aged mice have significantly reduced expression of surrogate light chains and poor preBCR function. This results in progressive alteration of the 5 heavy chain repertoire in newly formed B cells in aged mice. However, rather than a random loss of pre-B cells in old age, we propose that the aged pre-B compartment will become skewed in favor of those pre-B cells that undergo positive selection even when surrogate light chain is highly reduced. Moreover, we propose that increases in autoreactivity as well as detrimental changes in the availability of protective antibody responses to pathogens, e.g., S. pneumoniae, are, in part, due to a compromised preBCR checkpoint. To address this hypothesis, we propose 3 integrated Specific Aims. In Specific Aim 1, we ask Does compromise of the preBCR checkpoint in old age 'reshape' the Vh repertoire and promote autoreactivity? Here, the effects of diminished preBCR function on 5 heavy chain usage, and capacity to signal when surrogate light chain is low, will be determined together with impact on autoreactivity. Specific Aim 2 addresses the fate of autoreactive immature B cells within the bone marrow of aged mice and their contribution to the peripheral B cell pools. Tolerance among immature B cells in aged mice, their capacity to home to the spleen, and, importantly, the expression of protective versus non-protective clonotypes in response to the S. pneumoniae antigen phosphorylcholine will be assessed. Specific Aim 3 focuses upon the importance of proinflammatory cytokines (TNFa) and effector cells (NK) in triggering the down-regulation of preBCR, altering both B lymphopoiesis and antibody repertoires in aged mice. These studies will advance understanding of the immune defects that accompany old age and their cellular and molecular mechanisms.

Public health relevance
PUBLIC HEALTH RELEVANCE: The development of new antibody producing B cells is compromised in old age. This may result in both poor antibody protective responses to pathogens in disease as well as to vaccination. Our studies focus on the mechanisms that affect antibody producing B cell production in old age, primarily the role of the pre-B cell receptor complex. Insight into the defects in B cell production in old age may reveal their influence on developing and maintaining effective immune barriers to infectious disease. The development of new antibody producing B cells is compromised in old age. This may result in both poor antibody protective responses to pathogens in disease as well as to vaccination. Our studies focus on the mechanisms that affect antibody producing B cell production in old age, primarily the role of the pre-B cell receptor complex. Insight into the defects in B cell production in old age may reveal their influence on developing and maintaining effective immune barriers to infectious disease. __SpecificAimsTextDelimiter__ HYPOTHESIS and SPECIFIC AIMS: In old age, B lymphopoiesis is reduced, B lymphocyte homeostasis is altered, and antibody repertoires are changed. The pre-B cell receptor (preBCR; Ig m heavy chain + surrogate light chains (SL) l5 and VpreB) drives pre-B cell expansion and selects m heavy chains. In aged mice, we propose that: 1) low SL prevents adequate preBCR signaling; 2) only a fraction of pre-B cells can use limited SL to form the preBCR and enter the B cell pathway; 3) alterations in pre-B cells, and their immature B cell progeny, affect the peripheral antibody repertoire-in particular the anti-phosphorylcholine (PC) response important to defense against S. pneumoniae; and 4) changes in the aged bone marrow microenvironment, as a consequence of systemic "inflamm-aging" (TNFa) and local changes (e.g., NK cells), trigger the down regulation of SL in old B cell precursors. "Antibody repertoire reshaping", promoting autoreactivity and compromising protective antibody clonotypes, may impair defense against pathogens in old age. SPECIFIC AIM 1: Does compromise of the pre-B cell receptor checkpoint in old age "reshape" the Vh repertoire and promote autoreactivity? A. Do pre-B cells in aged mice, with low surrogate light chain, undergo positive selection or represent an "unselected" Vh repertoire? Proliferation, productive to non-productive m chain rearrangement, and 3' vs. 5' Vh family expression in pre-B cells will be assessed in aged mice and l5 KO mice (preBCR deficient). Assess preBCR assembly in aged B cell precursors together with signaling capacity. B. Does abrogation of preBCR-mediated selection in bone marrow coincide with increased autoreactivity in aged bone marrow and spleen? The expression of anti-phosphorylcholine (PC; T15+ and T15- idiotypes), as well as anti-nuclear antigen B cells, will be determined in immature and follicular B cells from bone marrow and spleen of l5 gene KO mice as well as wild-type aged mice deficient in SL. SPECIFIC AIM 2: What are the fates of autoreactive immature B cells within the bone marrow and do they contribute to recirculating/peripheral B cell pools? A. Are immature B cells in aged bone marrow more self-reactive and do they undergo tolerance (receptor editing/dilution; anergy)? The self-reactivity of immature B cells to nuclear antigens and to the self antigen PC in T1, T2, T3 and a unique CD43+ T2/T3 subset will be tested by ELISpot assay in young and old wild-type and l5 KO mice. Receptor editing and light chain "shifts" as well as B cell anergy (altered calcium mobilization and phosphorylation) will be determined in B cell subsets from bone marrow of aged mice. B. Do immature B cells from aged bone marrow, with altered and autoreactive antibody repertoires, migrate to spleen? In aged mice: 1) Immature B cells in peripheral blood will be measured; 2) migration of cohorts of BrdU labeled immature B cells will be "traced"; and 3) homing after i.v. adoptive transfer of defined immature B cell subsets will be studied. C. Are the non-protective T15- anti-PC clonotypes and T15+ protective anti-PC B cells sequestered in distinct immature B cell pools in old age? The representation of T15- and T15+ anti-PC B cells within the bone marrow immature B cell subsets will be determined by both ELISpot assay and splenic focus assay and compared with that of splenic transitional B cells. SPECIFIC AIM 3: Does "inflamm-aging" initiate B cell "antibody repertoire reshaping" in old age? A. Are proinflammatory cytokines increased in aged mice commensurate with decline in B lymphopoiesis? TNFa, IL-1, IL-6 levels in serum from aged mice will be assayed and correlated with B cell precursor levels in bone marrow. Neutralization of TNFa in aged mice will be used to assess function. B. Do NK cells provide TNFa that down-regulates B lymphopoiesis in old age? Whether increases in bone marrow NK cells coincides with deficits in B cell precursors or key molecules (E2A and l5) in old age will be determined. In vivo, NK cells from aged B6 mice will be depleted with anti-NK1.1 mAb and effects on a) serum TNFa; b) pro-B/pre-B cells; c) E2A and surrogate light chain expression will be determined. C. Does "inflamm-aging", via TNFa, promote low preBCR in aged B cell precursors and/or alter the stromal cell microenvironment in bone marrow? Capacity of proinflammatory cytokines, particularly TNFa, to inhibit expression of surrogate light chain and the "preBCR transcription factor profile" in B cell precursors will be assessed and the molecular mechanisms investigated. Alterations in the stromal microenvironment (e.g., CXCL12 synthesis) by TNFa will also be assessed.